Therapeutic antibodies for treating liver fibrosis

ABSTRACT
Cirrhosis of the liver is among the top ten leading causes of death in the US, with more than 35,000 deaths each
year. A major underlying cause of cirrhosis is liver injury associated with liver fibrosis, i.e., scar tissue that blocks
the flow of blood through the liver, raising blood pressure and disturbing normal function. There are no approved
drugs for fibrotic non-alcoholic steatohepatitis (NASH), which often progresses to cirrhosis, so patients are often
left with “lifestyle modifications” that are difficult to sustain, and, at best, put patients in a race against disease
progression. CB2 agonism is a promising mode of action for treating liver fibrosis/NASH. Small molecule agonists
of the cannabinoid receptor CB2 have reduced liver fibrosis in several established animal models by inhibiting
hepatic immune cells and hepatic stellate cells. However, small molecule CB2 agonists have drawbacks,
including cross-reactivity with pro-inflammatory/pro-fibrotic CB1 receptors in immune cells and psychotropic CB1
receptors in the CNS, and rapid elimination from the body. Therefore, a CB2 agonist antibody (Ab) that is highly
specific for CB2 over CB1, restricted from passing the blood-brain barrier into the CNS, and is long-lived would
be an ideal drug for liver fibrosis. Unlike small molecules, which often show liver toxicities, Ab drugs have
excellent safety track records in treating chronic diseases. Abalone Bio used its proprietary antibody discovery
platform to isolate a selective CB2-activating nanobody (VHH), ABt101. In Phase I, ABt101 was successfully
modified and reformatted into a VHH-Fc fusion antibody (ABt140) to increase its stability and in vivo half-life.
Feasibility of the CB2 Ab agonist for liver fibrosis was demonstrated using two complementary in vivo models.
In this Phase II SBIR project, Abalone Bio will improve ABt140’s immunogenicity an manufacturability by rational
engineering, and increase its potency by selecting stronger agonists from millions of computationally designed
variants using Abalone Bio’s proprietary functional Ab selection platform. Then, the selected candidate Ab will
be manufactured according to Good Manufacturing Practices (GMP) standards. Progress made in parallel to this
project in advancing the CB2 agonist Ab for another indication will cover remaining manufacturing development
and preclinical testing (i.e., IND-enabling tox studies). The proposed GMP production run will produce clinical
drug substance (DS) supply at 500L bioreactor scale, generating sufficient DS for phase I clinical studies in liver
fibrosis. In parallel, the candidate Ab will be tested for efficacy in two of the most relevant disease models of
NASH and fibrosis. The Ab will be applied to liver slices to understand the mechanism of action of the CB2
agonist in the context of endogenous cell-cell interactions. The FAT-NASH animal model will validate the
functional anti-fibrotic activity of the CB2 agonist at a lower dose level of the optimized antibody, and the TAA
model will test the activity of the CB2 agonist in a model of severe fibrosis. These studies will generate material
for clinical studies and help select the most suitable patient groups for treatment with the CB2 agonist antibody.

Public health relevance
NARRATIVE Abalone Bio is commercializing a highly specific, long-lived, peripherally restricted CB2 receptor agonist antibody as a means of attenuating and preventing fibrosis caused by chronic liver diseases. This Phase 2 project will advance this goal by (1) optimizing the stability and potency of the lead antibody drug, (2) further validating the mechanism of action in models of liver fibrosis and (3) producing a batch of the lead antibody in anticipation of clinical trials.